Cortical Regulation of REM Sleep

PROJECT SUMMARY
Rapid eye movement (REM) sleep is characterized by intense cortical activation, giving rise to its wake-like
electroencephalogram (EEG). Disturbances in REM sleep are symptomatic of mood disorders including major
depressive disorder (MDD), which is associated with dysfunction of the prefrontal cortex (PFC). However, to
what extent altered cortical activity in mood disorders may directly cause changes in REM sleep remains largely
unknown. Particularly, because REM sleep is thought to be primarily controlled by subcortical nuclei, the
mechanisms by which the PFC may regulate REM sleep are unknown. A prominent biomarker for depression is
an increase in phasic REM sleep, reflected in an increased density (frequency) of rapid eye movements during
REM sleep. However, despite its clinical relevance, the mechanisms and brain structures underlying the
regulation of phasic REM sleep are still largely unknown.
Our preliminary results show that pyramidal neurons in the medial PFC (mPFC) promote REM sleep in mice
through their projections to the lateral hypothalamus (LH). In addition, we found that activation of mPFC
pyramidal neurons enhances the density of rapid eye movements during REM sleep. The central objective of
this proposal is to identify the neural mechanisms by which the mPFC regulates the induction and maintenance
of REM sleep and rapid eye movement density. This will be accomplished in two aims. First, we will combine in
vivo calcium imaging, optogenetics, optrode recordings, and viral tracing to identify the activity, connectivity, and
functional role in brain state regulation of the LH neurons innervated by the mPFC. Second, we will investigate
the mechanisms by which the mPFC regulates rapid eye movements during REM sleep. We will combine
pupillometry with optogenetic manipulation, in vivo calcium, and optrode recordings to examine whether the
axonal projections from the mPFC to the pons induce rapid eye movements and test whether mPFC neurons
and their postsynaptic pontine neurons are recruited during rapid eye movements. Unraveling the mechanisms
by which the mPFC controls REM sleep and the rapid eye movement density is a critical precursor to resolving
the causal relationship between changes in prefrontal circuits associated with depression and REM sleep
disturbances. Our results have the potential to develop more refined biomarkers to infer from disturbances in the
regulation of REM sleep and rapid eye movements information about the integrity of prefrontal circuits in health
and disease.

Public health relevance
NARRATIVE Sleep in depression is characterized by disinhibited rapid eye movement (REM) sleep with an increased density of rapid eye movements. The proposed studies aim to dissect the circuit mechanisms by which the prefrontal cortex, a brain area hyperactivated in depressed patients, regulates REM sleep and the eye movement density through interaction with subcortical areas in hypothalamus and brainstem. The results are a critical precursor to understanding the causal relationship between cortical dysfunction in psychiatric disorders and sleep disturbances.